11th International gamma delta T Cell Conference

ABSTRACT
The 11th International gd T Cell Conference will be held at the Hilton Toronto, Ontario, Canada, from May 20 to
May 23, 2025. This is the eleventh iteration of a biennial conference, which is the only meeting specifically
dedicated to the topic of gd T lymphocyte development and function, and how these cells could be used to
develop new cell-based therapies. The conference therefore has a unique scientific content that bridges the
highly dynamic and prolific fields of adaptive and innate immunity, and is relevant to tissue homeostasis,
inflammation, infection, and cancer treatments. Notably, the conference provides several unique features,
including (i) a singular focus on gd T cell biology; (ii) affordable cost to all attendees, with additional subsidies for
trainees; (iii) a rich selection of presentation opportunities, with special attention to trainees; and (iv) a very
stimulating interactive environment, providing trainees with access to leaders in the field throughout their time at
the conference. The 2025 International gd T Cell Conference will bring together an international group of
investigators working on all aspects of gd T cell biology to discuss unpublished results and develop new
paradigms and directions for future research.

Public health relevance
PROJECT NARRATIVE/RELEVANCE STATEMENT This conference will encourage the enthusiastic exchange of scientific information and highlight relevant basic and therapeutic advances in  T cell biology between US, Canadian, European, Asian, and Australian scientists, and will enable trainees to share their research and advance their careers by interacting with senior scientists from these countries. This will lead to new insights into the mechanistic bases for immunity to infection, autoimmunity, and cancer.